Viral and Host Dynamics during Pediatric COVID-19 and Respiratory Virus Co-Infection

PROJECT SUMMARY
Children infected with SARS-CoV-2 are frequently reported to have co-infection with other respiratory viruses,
including respiratory syncytial virus, human rhinovirus/enterovirus, and parainfluenza virus. Respiratory virus co-
infection may lead to more severe COVID-19 and worse clinical outcomes, but this is complicated by
ascertainment biases in clinical testing algorithms that make co-detection of multiple respiratory pathogens more
likely in the most at-risk and severely ill children. Severe COVID-19 outcomes have been previously linked to
immune dysregulation following infection, but it is unknown how the host response to SARS-CoV-2 may be
influenced by co-infection with another respiratory virus. Likewise, it is unclear what impact co-infection may
have on intra-host viral dynamics, including viral load, time to clearance, and viral diversification, all of which
may contribute to the evolution of new variants with enhanced immune evasion or antiviral resistance. We
hypothesize that children with SARS-CoV-2 experience frequent respiratory virus co-infection, and that this co-
infection is associated with more severe disease, increased inflammation and mucosal injury in the upper
respiratory tract, and enhanced viral diversity due to increased persistence and viral load. We propose to test
this hypothesis in three aims designed to: 1) assess the prevalence of SARS-CoV-2 and respiratory virus co-
infection and its association with clinical outcome; 2) characterize the mucosal immune response to SARS-CoV-
2 and how it differs in response to viral co-infection; and 3) determine the influence of co-infection on viral intra-
host dynamics and evolution. To achieve this goal, we will leverage our retrospective biobank of residual COVID-
19 diagnostic specimens from Lurie Children’s Hospital (n>6000 specimens collected since March 2020) as well
as prospectively collected specimens spanning a total of 6 years. In Aim 1, we will use a combination of multiplex
PCR and hybrid-capture sequencing to establish respiratory virus co-infection prevalence over time. Electronic
medical record data will be used to examine associations between co-infection, clinical outcomes, and disease
severity, adjusting for relevant demographic and clinical cofactors, including treatment, vaccination, and prior
infection. In Aim 2, bulk transcriptomic sequencing, cytokine profiling, immune cell profiling, and single-cell RNA
sequencing will be used to assess the mucosal immune response in co-infected individuals and controls. Host
response data will be modeled in the context of the extracted demographic and clinical metadata to determine
association with disease severity and outcomes. In Aim 3, viral whole genome sequencing and quantitative PCR
will be used to assess viral load, intra-host quasispecies composition, and genetic diversity. Phylogenetic and
phylodynamic models will be used to determine evolutionary rate and selection. Mutations in antiviral drug targets
will be assessed for resistance potential. Taken together, these data will clarify the prevalence, clinical impact,
and virus-host dynamics underlying SARS-CoV-2 and respiratory virus co-infection in children towards the
development of evidence-based guidance to optimize diagnosis/treatment and minimize morbidity.

Public health relevance
PROJECT NARRATIVE Children infected with SARS-CoV-2 are frequently reported to have co-infection with other respiratory viruses, which potentially results in worse COVID-19 clinical outcomes. Here, we propose to leverage a biobank of residual diagnostic specimens from children with COVID-19 to determine the prevalence of respiratory viral co- infection, its association with clinical outcome, its influence on the host immune response, and its influence on viral evolution. These data will help inform best practices in diagnosis and treatment of respiratory virus co- infection to minimize child and adolescent morbidity and mortality.